Clinical Impact and Epidemiology of Nonsteroidal Anti-inflammatory Drug Allergies

PROJECT SUMMARY/ABSTRACT
Nonsteroidal anti-inflammatory drugs (NSAIDs) are indicated for first-line treatment of many conditions ranging
from pain to heart disease, but therapeutic use of the entire medication class can be precluded by reported
allergy. While NSAIDs represent the second most commonly reported class of drug allergies, it is estimated
that <20% of reported NSAID-induced reactions are consistent with allergic hypersensitivity (eg, urticaria,
angioedema, anaphylaxis), with the rest representing non-allergic side effects or intolerances (eg,
gastrointestinal upset, bleeding, nephrotoxicity). Allergy over-reporting and lack of reaction clarification can
lead to unnecessary drug avoidance, and increased use of second line, more costly, and less effective
alternative medications, with resultant downstream adverse effects on patient outcomes. The primary objective
of this proposal is to determine the impact of reported NSAID allergies on prescribing patterns and clinical
outcomes in distinct populations and to define predictors for true NSAID-induced allergic hypersensitivity. The
proposed study has three Aims: (1) to assess the impact of reported NSAID allergy on postoperative opioid
prescribing and sustained opioid use in a large electronic health record-derived cohort of patients undergoing
common surgical procedures; (2) to evaluate differences in aspirin administration and adverse cardiovascular
outcomes in patients with acute coronary syndromes with and without reported NSAID allergy; (3) to use a
well-defined cohort of subjects who have undergone allergist-observed NSAID drug challenge to determine
patient- and drug-specific risk factors for NSAID-induced hypersensitivity. Dr. Li’s research plan will be
supported by coursework and training in clinical and epidemiological study design, advanced biostatistical
methods for research with large datasets, informatics, patient recruitment, and drug-challenge protocols, and
the exceptional scientific environment at the University of Washington. This K23 proposal is well-aligned with
NIH initiatives to reduce unnecessary opioid prescribing and NIAID support of drug allergy research, and will
position the candidate to submit an R01 application during the award period and to establish herself as an
independent patient-oriented investigator with a focus on improving the care and health of patients with drug
allergies.

Public health relevance
PROJECT NARRATIVE Nonsteroidal anti-inflammatory drugs (NSAIDs) are recommended for first-line therapy of many conditions, but allergy over-reporting and lack of reaction clarification may lead to unnecessary avoidance of NSAIDs and increased use of second line, more costly, and/or less effective treatments. Our study aims to determine how NSAID allergy labeling influences alternative medication prescribing and patient clinical outcomes, and to identify predictors for true NSAID-induced allergic hypersensitivity. This work will inform the development of new evidence-based approaches to risk stratify and target previously overlooked populations for allergy intervention, allowing delabeling and providing safer management and improving the care of drug-allergic patients.